Leveraging multiple Common Fund datasets to rank cell-cell interactions for faster hypothesis generation

Project Summary
Cell-cell interactions (CCIs) are crucial to the maintenance of proper cell functions in tissues, particularly those,
like barrier tissues, that orchestrate complex responses to invading pathogens and environmental signals.
There are significant opportunities for leveraging existing datasets to generate biological insight by better
understanding how CCIs and core transcriptional signatures of cells orchestrate tissue function or disease.
Single-cell transcriptomic datasets allow for comprehensive prediction of CCIs in a given disease or tissue of
interest. Many computational techniques have been developed to identify ligand-receptor pairs that mediate
these CCIs using either bulk and single cell datasets, as well as spatial transcriptomic datasets. However, the
analysis of transcriptomics data produces thousands of ligand-receptor interactions that difficult to prioritize for
experimental validation. Thus, there is a need for a computational tool that will rank CCIs for experimental
validation. Here we propose to create a database of putative CCIs across several epithelial barrier tissues,
including skin, intestine, and reproductive tissue. We will then employ a ranking system that uses information
from several Common Fund datasets to rank cell-cell interactions for experimental validation. Finally, we will
validate our approach using existing spatial transcriptomic datasets. Overall, the results of this work will
leverage the wealth of existing data to better contextualize CCIs, allowing the scientific community to prioritize
novel CCIs for experimental validation.

Public health relevance
Project Narrative: Cell-cell interactions (CCIs) are crucial to the maintenance of proper cell functions in tissues, particularly barrier tissues that orchestrate complex responses to invading pathogens and environmental signals. There are many methods for inferring CCIs but very few for ranking these to prioritize for detailed and costly experimental validation. Here we propose to create a database of putative CCIs across several epithelial barrier tissues, including skin, intestine, and reproductive tissue and a novel ranking system that leverages Common Fund datasets to prioritize CCIs for experimental validation.